Translational imaging biomarkers of the tumor microenvironment in early prostate cancer

Project Summary
The goal of this translational project is to link the genetic and cellular features of the overarching, proving ground
[cancer-permissive tumor microenvironment (TME)] hypothesis of this U54 application to imaging biomarkers
that can be used clinically to detect and ultimately intercept prostate cancer. Little is known about the cellular
subtypes that participate in the epithelial-stromal interactions in prostate cancer, or about the timing of their
appearance during progression. We have developed a series of translational imaging agents designed to
measure cancer epithelium and specific cells within the TME. We will leverage a subset of those agents to
understand quantitatively the TME in prostate cancer so that it can be detected and reprogrammed early during
malignant transformation. In Aim 1 we will image patients with primary prostate cancer prospectively with multi-
parametric magnetic resonance imaging (mpMRI) and 18F-DCFPyL (PyL) positron emission
tomography/computed tomography (PET/CT), which targets the prostate-specific membrane antigen (PSMA).
We will perform standard-of-care PyL PET/CT imaging on patients with intermediate to high-risk prostate cancer
prior to prostatectomy. We will quantify and correlate between imaging and pathology with the hypothesis that
PSMA-low regions in otherwise high-grade tumors correlate with adverse pathology at prostatectomy in an effort
to understand better the heterogeneity of primary disease. We will also compare PyL PET/CT with the cellular
composition and spatial architecture of immune and stromal compartments of the prostate cancer TME. We will
also retrospectively use prostatectomies from the same patients that were consented for genomic studies in
Project 2. We will test the hypothesis that PyL PET/CT measured PSMA levels will directly correlate with MYC
expression, MYC copy number gain, PTEN loss, and TP53 mutation. We will also determine in an unbiased
manner which gene expression, genomic and epigenomic alterations best correlate with PSMA PET imaging
features. We will also employ radiomic and machine-learning approaches not only to subtype patients with
prostate cancer into prognostic groups, as we have done before, but also to predict who may have aggressive
disease on initial PyL PET/CT staging. For this we will require merging not only the mpMRI and PyL PET/CT
data, but also the histopathology, relevant genomics, and available protected historical information. Aims 2 and
3 involve longitudinal studies in the BMPC murine model, which we have developed and recapitulates human
prostate cancer according to a specific timetable. We will determine the extent of macrophages and cancer-
associated fibroblasts in and around the BMPC tumors as they develop over time and correlate their presence
with imaging by small animal PET/MR. We will use novel imaging agents that we have developed, which target
CSF1R (macrophages) and FAP (CAFs), and correlate the results with immunohistochemistry and genomics.
Through careful radiologic-pathologic correlation, this project will provide rationale for future clinical studies to
understand better the TME in prostate cancer, and how it can be reprogrammed to combat this disease.